Training Program in Vision Science

Abstract
The Vision Science Training Program at UC Davis seeks 4 predoctoral and 1 postdoctoral
training positions to broaden the skills and research perspective of the future biomedical and
academic workforce by providing specialized training in the basic science of vision. The
training environment includes 36 faculty vision researchers (22 preceptors and 14 associates)
across 9 departments located in 5 different schools/colleges, and draws upon on the rigorous
admission standards and course structures of the 5 graduate programs of our participating
preceptors. Each of the preceptors has an active program of vision science research, a
demonstrated commitment to training, and strong extramural funding, with over $10M in
annual direct costs (2016-2017). Resources for vision science training are augmented by a
ﬁnancial and infrastructural institutional commitment, the UC Davis Center for Visual Sciences,
and an NEI Core grant. The program offers unique training opportunities that include quarterly
faculty ﬁreside chats, monthly brown bag trainee chalk talks, an annual retreat, and a one-year
vision survey course that broadly covers basic and clinical vision sciences with contextual
emphases on modern methods, experimental design, biostatistics, and ethics. All trainees will
be engaged in vision science research that will be presented at national meetings and
submitted to peer-reviewed journals. Under the advice and mentorship of their preceptor,
trainees will utilize Individualized Development Plans (IDPs) and annually discuss the IDPs
with members of the Advisory Committee to ensure efﬁcient progress toward employment in
their desired niche within the biomedical workforce.

Public health relevance
Project Narrative This grant will provide support to continue high quality training grounded in basic science disciplines, and to broaden the research perspective and skills of future vision scientists. The program is designed to have a significant impact on the health and science agendas of the National Eye Institute and to prepare the next generation of vision scientists to enter the biomedical workforce.